Administrative Core

The Administrative Core will oversee the organizational, financial, and scientific activities of the overall project, the day-to-day operations and also coordinate administrative and scientific reviews. Core personnel will coordinate the activities with the Divisions, Departments and Schools whose investigators are participating in the Program and with investigators from outside the University of Pittsburgh. The Administrative Core is critical to: 1) provide scientific and administrative leadership; 2) foster scientific interchange and communication within the Program, with outside institutions and with the Internal Advisory board and 3) provide operational oversight to the projects and the two other cores. The specific aims of the Administrative Core are to: 1. Provide scientific leadership and oversight to the Projects and other Cores. 2. Coordinate and foster scientific interchange amongst investigators within the Projects and Cores and between Project members and other interested parties in the University of Pittsburgh research community for progress of the proposed studies. A key function of the Core would be to ensure timely reporting of data to the scientific community through presentations at scientific conferences and publications in peer-reviewed journals. 3. Provide operational oversight and administrative, regulatory and financial support to the Projects and other Cores.